SYNTHESIS OF THERAPEUTICALLY IMPORTANT ALKALOIDS

The development of efficient synthetic routes to biologically important small molecules constitutes the major focus of the grant application. In the majority of the studies outlined herein, the reactive dipole, a nitrile oxide, will be added in either an intramolecular or intermolecular fashion to an alkene to furnish a substituted isoxazoline. By properly processing the isoxazoline, access to either a Gamma-amino alcohol or a Beta-hydroxy ketone can be achieved. The following topics represent the specific objectives to be accomplished during the requested grant period: (1) Ergot Alkaloid (used in treatment of hypertension, migrane attacks, postpartum hemorrhage etc.) Studies: (a) develop a route to lysergic acid; (b) prepare other ergots from a common precursor; (c) synthesize clavicipitic acid and aurantioclavine (biological properties unknown); (d) examine an ene route to Alpha-cyclopiazonic acid (mycotoxin); (e) synthesize possible biogenetic precursors to the ergolines for feeding studies; (2) Five-membered Ring Synthesis: (a) examine a route to protaglandins (tissue hormones); (b) use the diasteroselective intramolecular nitrile oxide cycloaddition (INOC) reaction to prepare integerrinecic acid and a fragment of macbecin (antitumor activity); (c) ascertain the ability of homoallylic and bis-homoallylic asymmetric centers to control diastereoface selectivity in the INOC reaction - prepare a fragment of palytoxin; (3) Develop an INOC Route to Mitomycins (antitumor activity); (4) Develop an INOC Route to Morphine (narcotic analgesic); (5) Develop a (3+2) approach to C-Nucleosides (antibiotic, antiviral and antitumor activity); (6) Develop a Chiral-Selective Syn-Carboxyhydroxylation Process.